Mapping polymicrobial interactions that modulate antibiotic persistence

Abstract:
The discovery of antibiotics in the early 20th century has transformed modern medicine; yet decades of use,
overuse, and misuse have culminated in the rapid rise in pathogens that are refractory to our existing drugs.
Antibiotic resistance is not the only reason for treatment failure. Within antibiotic-sensitive cultures,
subpopulations of bacteria can transiently reprogram their phenotype, which enable them to survive lethal
antibiotic doses. These bacterial persisters are thought to underlie recurrent and chronic infections, and they
can fuel the development of resistance. Mounting evidence shows that environmental factors modulate
phenotypic changes that lead to antibiotic persistence before, during, and after treatment. As such, achieving a
deeper understanding of the interplay between environmental cues, bacterial phenotypic responses, and
antibiotic susceptibility will improve our ability to devise more effective treatment regimens.
When pathogens colonize and infect different parts of the host, they are often exposed to other pathogens and
constituents of the host microbiome. The extent to which microbial interactions modulate a pathogen's
phenotype and antibiotic persistence remains largely unexplored. Our overarching objective for this project is
to systematically investigate the impact of microbiome constituents on Staphylococcus aureus's phenotypic
response and persistence to antibiotics. To achieve this goal, we will develop a co-culturing phenotypic screen
to identify bacterial strains and communities that impact S. aureus antibiotic persistence toward distinct
classes of antibiotics. Using a combination of transcriptomics, metabolomics, and single-cell approaches, we
will determine how these microbial interactions modulate S. aureus phenotypes (on the population- and single-
cell level) before, during, and after antibiotic treatment. We will also use analytical techniques to identify
molecular determinants that mediate microbial interactions responsible for the strongest effect on S. aureus
persistence. We envision that the outcome of this project will expand our knowledge of the persister
phenotype, contribute to the discovery of novel antimicrobial adjuvants, and guide the development of
innovative treatment strategies to tackle chronic infections.

Public health relevance
Project Narrative: Antibiotic treatment failure is a major global public health threat. In addition to acquiring antibiotic resistance, bacteria can transiently reprogram their phenotype, which bolsters their ability to survive high-dose antibiotic treatment. This work will enhance our knowledge of how interactions with a host's microbiome impact bacterial responses and susceptibly to different classes of antibiotics, which can potentially improve our ability to treat recurrent infections.